Admin-Core

ABSTRACT: ADMINISTRATIVE CORE
The Lineberger Comprehensive Cancer Center (LCCC) Administrative Core includes the Senior Leadership
Team (SLT) and Center Administration. The SLT establishes the overall strategic direction and research
mission for LCCC and center Adminstration operationalizes this vision. The SLT includes the Director, Deputy
Director of Clinical Science and Associate Directors of Basic, Translational and Population Science; Education
and Training; Community Outreach and Engagement; and Administration and meets weekly to consider all
matters impacting LCCC. Center Administration provides infrastructure to promote the cancer research
activities of its 324 members, with a particular focus on facilitating transdisciplinary and translational cancer
research with relevance to the catchment area, the State of North Carolina, and informed by bi-directional input
from the community. The Administration supports the Director, Senior Leaders, Program Leaders, Shared
Resources Directors and LCCC Members in carrying out the Center mission through effective strategic
planning and evaluation, operational management, and centralized resources.
LCCC Administration (80 FTE/$6.3M) oversees the largest research operation at the University of North
Carolina including a $165M budget (FY19) covering grant and fiscal management and other administrative
services for faculty members and 13 Shared Resources. Many of these reside in center-controlled space
(165,000 nsf) which the administrative staff also manages. The administrative staff is responsible for human
resources and administering partial salary support for over 1200 FTEs. Administrative responsibilities include:
management of Center finances, personnel, grants and contracts, purchasing, and philanthropy; providing
administrative and financial oversight for LCCC shared resources; overseeing space utilization and common
equipment; facilitating recruitment efforts; managing center membership; and coordinating pilot award
programs. Additional activities involve coordinating Center planning and evaluation activities including
leadership and programmatic meetings, seminars, annual symposia and retreats, and internal and external
board meetings. The administrative staff also supports communication to the 324 LCCC members and the
University as a whole as well as educating citizens and legislators regarding Center activities across the state.
The Administrative Core monitors and reports on member accomplishments, funding, cancer-related activity to
the membership committee and SLT as a part of the annual membership evaluation. The conduct of surveys
and evaluation for planning is also a function of the central administrative staff. The Administrative Core
functions are overseen by an Associate Director for Administration with more than 15 years of experience at
UNC.